Real world use of anti-obesity medications to treat adolescent obesity: moving beyond the clinical trial

PROJECT SUMMARY/ABSTRACT
One in five US adolescents have obesity, making pediatric obesity a significant public health problem. Safe and
effective treatment options exist for adolescents with obesity including motivational interviewing, intensive health
behavior and lifestyle therapy, pharmacotherapy, and metabolic and bariatric surgery. Recently, several anti-
obesity medications (AOMs) have been approved for use in adolescents, showing great promise for reducing
obesity. However, to date, these AOMs have only been studied in tightly controlled clinical trials. While clinical
trials have high internal validity and provide evidence for efficacy of pharmacological approaches, they are limited
in their external validity and real-world generalizability. This has lead to gaps in our understanding of adolescent
AOM use including knowledge of the reach of AOMs in youth, effectiveness within real-world clinical settings,
and possible unintended consequences of AOM use. It is imperative that these gaps are addressed to ensure
that adolescents receive safe and effective clinical care. Therefore, the objective of this project is to collect real-
world evidence that can be used to inform clinical practice, improve health outcomes, and ensure patient safety
among adolescents using AOMs. The proposed project will recruit a cohort of adolescents using AOMs (12-17y;
n=200) from two pediatric obesity treatment clinics. In Aim 1, we will characterize the population of youth using
AOMs by examining demographic characteristics from the electronic health record of cohort youth compared to
those who are eligible, but never prescribed AOMs. In Aims 2 & 3, cohort participants will be followed for 18-
months, completing four study visits that will include measure of body composition, diet, physical activity, mental
health and quality of life. A subset of patients will complete DXA scans to further assess changes in body
composition and semi-structured interviews to yield richer contextual information. Data will also be obtained from
the electronic health record and assessments of adherence throughout the duration of cohort participation. In
Aim 2, effectiveness of AOMs will be evaluated by examining change in relative BMI among cohort youth
compared to the youth not utilizing AOMs from Aim 1 using propensity weighting approaches. Additional
analyses will examine the relationship between changes in diet, physical activity and study outcomes as well
describe adherence to AOM treatment protocols including medication switching and discontinuation. In Aim 3,
we will consider the unintended consequences of AOM use including longitudinal changes in mental health,
development of disordered eating behavior, and changes in DXA measured body composition and bone mineral
density. Overall, this project will provide valuable clinical evidence around AOM use in adolescents by addressing
key gaps in our knowledge of access, effectiveness and factors that influence effectiveness, and potential
unintended consequences. Successful completion of this project will inform clinical recommendations around
adolescent AOM use and has broader implications for implementation of AOMs among specialized obesity
treatment centers and general pediatric clinics.

Public health relevance
PROJECT NARRATIVE Anti-obesity medications are highly efficacious, yet much of the evidence has only been generated in clinical trials, which often lack generalizability to real-world, clinical settings. The proposed research will create and follow a cohort of adolescents taking anti-obesity medications to address gaps in our knowledge of access to these medications, real-world effectiveness and the factors that impact effectiveness (e.g., adherence, lifestyle changes), and unintended consequences associated with medication use. With the changing landscape of pediatric obesity medicine, findings from this study will guide clinical decision making to ensure that adolescents prescribed anti-obesity medications receive safe and effective clinical care.